11th World Congress on Stuttering and Cluttering

PROJECT SUMMARY
This grant seeks support for graduate student and early career faculty travel to attend the 11th World Congress
on Stuttering and Cluttering (formerly referred to as the “International Fluency Association Joint World
Congress”) to be held May 15-19, 2024 at the Moody College of Communication at the University of Texas at
Austin (Austin, Texas, United States).
The World Congresses have a long and distinguished history going back almost 30 years, and have long
attracted both senior and junior researchers and clinician attendance. It publishes proceedings, and many
Congress contributions have gone on to both publication and citation in other research publications. The 2024
World Congress has paired with other major organizations to broaden participation and impact. Although
financially enabled by commitments of the World Stuttering and Cluttering Organization (WSCO, formerly
referred to as the “International Fluency Association”) and the Arthur M. Blank Center for Stuttering Education
and Research, it will also engage with the International Cluttering Association and the International Stuttering
Association (representing consumers and families world-wide). This broad inclusion is meant to strengthen the
development of Whole-Person Care approaches that most closely meet the needs of people who stutter and/or
clutter and their families.
The need for junior researcher attendance at the World Congress is of significant importance given the declining
numbers of faculty researchers in communication sciences and disorders, in the United States and abroad, and
in fluency disorders specifically. Past meetings have greatly contributed to the development of early career
investigators who have gone on to achieve well in their research, publication, and funding careers. This meeting
will offer students and early career faculty two workshops designed to develop grantsmanship and publication
skills. It will also host a panel designed to mediate viewpoints of persons who stutter and/or clutter, researchers,
and clinicians on research needs in fluency disorders.
Taken together, this meeting of dedicated researchers, clinicians, and advocates should result in high quality
proceedings and peer-reviewed research publications. It should also facilitate long-term health impacts in
understanding and treating fluency disorders that will continue the positive contributions made by World
Congresses over the past three decades.

Public health relevance
PROJECT NARRATIVE This application seeks support for junior researcher attendance at the 11th World Congress on Stuttering and Cluttering (formerly referred to as the “International Fluency Association Joint World Congress”), to be held May 15-19, 2024 in Austin, Texas, USA. The World Congress is a joint effort of the World Stuttering and Cluttering Organization (formerly referred to as the “International Fluency Association”), the International Stuttering Association, and the International Cluttering Association, with additional support from the Arthur M. Blank Center for Stuttering Education and Research (Austin, Texas). Support recipients will also attend two training workshops designed to optimize preparation for grant applications and publication/tenure success.